ALZHEIMERS RESEARCH PROJECT: DNA repair dysfunction in neurodegeneration and Alzheimer's Disease

Our goal here is to determine whether changes in the formation or processing of oxidative DNA damage are associated with aging and neurodegenerative diseases (AD, PD). It is our hypothesis that DNA repair systems play critical roles in responding to multiple types of acute and chronic cellular stress. We have identified a DNA damage response cascade leading from PARP1 parylation to defective mitophagy.
This work underscores the important linkage between DNA repair and mitochondrial function and further points towards possible novel therapeutic interventions. We are continuing to explore the potential utility of NR for DNA repair-deficient disorders and in age-related diseases.